VEGF-C/VEGFR3 Regulation of VE-Cadherin in Sinusoidal Angiogenesis and Lymphangiogenesis

Research Summary
The blood, lymphatic, and sinusoidal vasculatures are molecularly and functionally distinct vascular networks
whose normal growth and development are essential to support embryogenesis. While there has been notable
effort to understand mechanisms of blood vessel development, relatively little is known about the role of
vascular endothelial growth factor (VEGF) receptor 3 (VEGFR3) and its main ligand VEGF-C in sinusoidal
development. Despite decades of work on VEGFR2 and VEGFR3 signaling, insights into the field have been
complicated by use of various genetic and pharmacologic models with divergent phenotypes. Furthermore,
VEGF-C can weakly bind and activate VEGFR2 in addition to inducing VEGFR2-VEGFR3 heterodimers. As a
result, the role of VEGF-C in vascular development remains incompletely understood. Therefore, our goal is to
determine the role of VEGF-C/VEGFR3 in vascular development and identify novel signaling mechanisms
through which it functions through a combination of in vivo mouse and in vitro cell culture studies. We and
others have previously identified VEGF-C as an important regulator of fetal liver hematopoiesis. This was
primarily attributed to defects in erythroid maturation, however the sinusoids are the only VEGFR3-positive
cells in the fetal liver. Strikingly, endothelial deletion of VEGFR3 and vascular endothelial (VE-)cadherin gain-
of-function mice both phenocopy VEGF-C knockout mice, suggesting that diminished fetal liver hematopoiesis
is in fact due to sinusoidal defects. These mice also have decreased bone marrow (BM) sinusoids. BM defects
due to endothelial loss of VEGFR3 are rescued by VE-cadherin haploinsufficiency, demonstrating that
VEGFR3 negatively regulates VE-cadherin to promote sinusoidal growth. Whether this process depends on
VEGF-C and the signaling mechanisms through which VEGFR3 regulates VE-cadherin remain unclear.
Therefore, I hypothesize that VEGF-C activates VEGFR3 to directly and negatively regulate VE-cadherin
during sinusoidal angiogenesis and lymphangiogenesis. Aim 1 will test whether haploinsufficiency of VE-
cadherin can rescue fetal liver and lymphatic growth defects, as I have demonstrated to be true in the bone
marrow sinusoids. Aim 2 will test whether VEGFR3 functions in a VEGF-C-dependent or independent manner
in the skin, liver, and bone marrow during sinusoidal angiogenesis and lymphangiogenesis. Finally, Aim 3 will
determine the mechanism by which VEGFR3 negatively regulates VE-cadherin through in vitro studies using
human lymphatic endothelial cells. Together, these studies will bring novel insights into the mechanism by
which VEGF-C/VEGFR3 may regulate VE-cadherin across various vascular beds in multiple organs, which
could have important implications for liver regeneration, BM reconstitution, and lymphatic disorders.

Public health relevance
Project Narrative Proper development of the sinusoidal and lymphatic vasculatures is essential for hematopoiesis and tissue fluid homeostasis. These vascular beds express vascular endothelial growth factor receptor 3 (VEGFR3), however the mechanisms that regulate and are regulated by VEGFR3 are not well understood. Proposed studies will investigate the role of VEGFR3 across multiple vascular beds and organs to better understand the pathways governing their development and to identify regenerative and therapeutic targets.